Assessing CSF flow dynamics in pediatric hemorrhagic hydrocephalus

Pediatric hydrocephalus affects 400,000 new children annually around the world. The primary etiology in the
developed world is neonatal post-hemorrhagic hydrocephalus (PHH), affecting around 1 in 16 premature
babies born at less than 29 weeks. Arising from the initial insult of intraventricular hemorrhage, subsequent
neuroinflammation, and disruption of the choroid plexus epithelium, PHH is manifested by progressive
ventricular dilation and increased intracranial pressure. PHH that can lead to significant disability and even
death.
The incomplete and evolving understanding of cerebrospinal fluid (CSF) flow dynamics limit the development
of improved strategies to prevent and treat PHH. Traditional bulk CSF flow models consider hydrocephalus to
be a plumbing problem with a mismatch in the rate of CSF generation and extracranial outflow. Several
preclinical studies have shown that neuroinflammation disrupts CSF-lymphatic extracranial outflow. We
hypothesize that in infants with PHH, impaired extracranial CSF outflow into the peripheral lymphatics
contributes to a vicious cycle of increasing neuroinflammation that may be responsible for initial treatment
failures and progressive insults that ensure irreversible brain injury.
In this pilot project, we will deploy a new technique, called fluorescence, cap-based transcranial optical
tomography (fCTOT) to understand the relationship between ventricular and lymphatic CSF dynamics,
measures of neuroinflammation, and outcomes to standard-of-care CSF diversion as well as endoscopic third
ventriculostomy and choroid plexus coagulation. Our specific aims are to:
(1) Conduct point-of-care, fCTOT imaging of ventricular Inodcyanine green (ICG)-CSF dynamics in infants with
progressing PHH;
(2) Measure ICG-CSF clearance into lymph/blood from point-of-care, non-invasive diffuse reflectance
measurements using NIRF-LI; and
(3) Correlate fCTOT-derived ICG-CSF dynamics, ICG-CSF clearance into lymph/blood, and CSF biomarkers
of inflammation with treatment outcomes.
If successful, this application will provide novel, critical information on the role of CSF dynamics for the
development of future prevention, progression, and treatment strategies for PHH. The study will be co-directed
by Manish Shah, MD, a neurosurgeon overseeing the care of a large PHH patient population; by Eva Sevick,
PhD., a biomedical engineer and early pioneer of near-infrared fluorescence optical tomography; and by
Banghe Zhu, PhD., an optical engineer who translated a non-contrast versus CTOT for rapid, whole-brain
tomography of PHH infants.

Public health relevance
Surgical treatment for post-hemorrhagic hydrocephalus (PHH) of premature infants is limited by our understanding of cerebrospinal fluid (CSF) production and circulation. In this pilot project, we will conduct transcranial, tomographic fluorescence imaging of CSF-indocyanine green (ICG) ventricular dynamics; assess CSF-ICG outflow into the peripheral lymphatics; and measure CSF biomarkers of inflammation in order to understand treatment responses of infants with PHH during standard-of-care treatments of conservative CSF diversion, endoscopic third ventriculostomy and choroid plexus coagulation.